ADOPTIVE TRANSFER OF IMMUNITY IN BONE MARROW TRANSPLANTATION

No study to date has addressed the questions of when donor immunization should occur in order to have an optimal number of primed B and T cells in the bone marrow or the stem cell harvest. This study is designed to: determine the optimal time interval to vaccinate autologous and allogeneic BM donors in order to maximize the frequency of antigen specific B-cells and T-cells in the bone marrow graft, demonstrate transfer of adoptive immunity to BMT recipients who receive bone marrow from recently vaccinated allogeneic or autologous donors, and study antigen specific B-cell and T-cell responses in vaccine recipients.